Retinoids in Vision

Vision is initiated when retinal photoreceptors respond to light via isomerization of the opsin-bound visual
chromophore 11-cis-retinal (11cRAL), releasing all-trans-retinal and triggering signal-transduction that transmits
visual information to the brain. Sustained vision requires continuous renewal of the chromophore, originally
thought to occur exclusively through the canonical visual (retinoid) cycle. Recent research advances have
identified alternative pathways for production of 11cRAL in the retinal pigment epithelium (RPE) and Müller cells
and developed gene-therapy approaches to restore 11cRAL synthesis in the setting of disease. These new
findings have raised key questions regarding the flow of 11cRAL and its metabolites within and between the
RPE, photoreceptors, and Müller glia, as well as the long-term efficacy of gene therapy to correct visual cycle
deficits. We will address these questions by using novel mouse models that enable study of subcellular
distribution of retinoids with unprecedented resolution and chemical specificity, and by applying newly developed
genome-editing technologies to compare the efficacy and longevity of gene alteration/correction versus currently
available gene-augmentation techniques to rescue retinal-disease models related to retinoid metabolism.
Aim 1: Elucidate the trafficking of 11-cis-retinoids within the neural retina. We developed a novel retinoid-
trapping method to isolate retinol isomers within specific cells and subcellular compartments, enabling robust
detection of these species by HPLC and in vivo two-photon microscopy, even when they are present as transient
intermediates under physiological conditions. This approach will enable definitive resolution of hypothesized
retinoid trafficking pathways that have, to date, not been possible to probe experimentally.
Aim 2: Determine the efficacy of genome-editing versus gene-supplementation therapy in rd12 mice.
Gene therapy is gaining prominence for treating deficiencies in visual-cycle enzymes. However, gene-
augmentation therapy has several drawbacks, including limited durability and persistence of the dysfunctional
gene. Genome editing can mitigate these shortcomings. We will compare the efficiency and durability of both
treatments. Mice expressing the mutant Rpe65 gene will be treated at different ages with Rpe65-AAV vectors,
or with virus-like particles (VLPs) delivering the genome editor; and therapeutic durability will be tested over time.
Aim 3: Develop genome-editing therapy for Rpe65-associated autosomal dominant retinitis pigmentosa
(adRP). We made an adRP mouse model that expresses the c.1430A>G (D477G) mutant of Rpe65. This
mutation serendipitously introduces a protospacer adjacent motif (PAM), enabling us to use CRISPR-Cas9 to
selectively inactivate the mutant gene and restore function. Alternatively, we will use prime editors to correct the
RPE65 deficiency with a long substitution extending from the PAM sequence. Editors and guide RNA will be
delivered using VLPs and lipid nanoparticles carrying Cas9-ribonucleoprotein cargo. We will optimize the editing
efficiency and evaluate treatment efficacy in restoring normal function in this adRP disease model.

Public health relevance
NARRATIVE Key processes in vision include the absorption of light by retinal rod and cone cells, triggering a phototransduction cascade that transforms the visual pigments and propagates an electrical signal to the brain, followed by regeneration of these pigments through the visual cycle. Despite significant advances in understanding the chemistry and biology of these pathways, fundamental questions remain. A deeper comprehension of these processes is crucial for elucidating the causes of human blinding diseases and developing innovative therapies to improve medical practice.